Large-scale, neuronal ensemble recordings in motor cortex of the behaving marmoset

Abstract
This project seeks to characterize the spatio-temporal organization of motor cortical (M1) activity at multiple
spatial scales associated with upper limb movements of unrestrained marmoset monkeys performing
ethological behaviors. The project has two goals: 1) To statistically evaluate the nature and stability of single
neuron and ensemble-level motor representations in M1 at the columnar and areal spatial scales, and 2) To
use our experimental data to develop a network model of a 3D patch of M1 capable of generating
experimentally testable predictions about the movement representations in M1. We will combine two
complementary technologies for large-scale neural recording: 1) wireless, high density multi-electrode arrays
and 2) calcium fluorescence imaging - while common marmoset monkeys (Callithrix jacchus) perform
naturalistic foraging behaviors. Advances in microelectrode array technology have permitted simultaneous
electrophysiological recordings from hundreds of neurons in behaving animals. However, given the large inter-
electrode distance (>=400 microns), much of the microcircuit activity at the subcolumnar level is unresolved. In
contrast, calcium fluorescence imaging provides the opportunity to densely and simultaneously record the
spiking activity of hundreds of neurons within a single cortical column. This dense, large-scale imaging allows
for the resolution of neurons immediately adjacent to one another which increases the likelihood that they are
synaptically connected. We will use a miniature fluorescence microscope attached to the skull which allows for
head-free, unconstrained movements of the arm and hand. Moreover, by adding a prism lens to the
microscope, we will be able to image neurons across lamina from layer 2/3 through layer 5. Using both
technologies, we will characterize single neuron encoding properties, network dynamics, and functional
connectivity within and between cortical columns. By bridging spatial scales, we will be able to interpolate
between the cortical microcircuit level and the level of a whole cortical area. We will also investigate how the
spatio-temporal organization of movement coding changes with motor skill acquisition. A unique and important
feature of this project will be the use of natural and unconstrained foraging tasks that involve prey capture
which will not require operant conditioning and will provide richer behaviors in order to build more accurate
encoding models. We will also build large-scale network simulations of a patch of motor cortex constrained by
the recorded data to understand how connectivity relates to tuning properties of single neurons. The model will
then allow us to investigate what synaptic rules result in the observed changes in spatiotemporal patterning
associated with motor learning. Ultimately, the principles of network dynamics, computation, and encoding
deduced from the motor cortex may apply more generally to other neocortical areas. This research may also
have applied relevance to brain-machine interface technology.

Public health relevance
This project seeks to discover the large-scale, spatio-temporal organization of movement representations in the upper limb area of motor cortex of primates performing natural foraging behaviors at an unprecedented spatial scale. By using state-of-the-art wireless, multi-electrode array and optical imaging technologies, we will enhance our understanding of the cortical basis of voluntary movement generation by bridging spatial scales from the microcircuit level to the entire forelimb area of motor cortex. This research could also have important implications for neural prosthesis development in humans by determining whether a more local, targeted approach using optical imaging would be viable for a cortically-controlled neural prosthesis and would result in less cortical damage.